Clinical Translation Core - RC3

Resource Core 3 (RC3) Clinical Translation Core: Project Summary The Johns Hopkins University (JHU) Older Americans Independence Center (OAIC) proposes to offer a resource core entitled Clinical Translation Core, or Resource Core 3 (RC3). This core—now in its 10th year— was designed to accelerate the translation of important biological findings related to frailty into clinical studies, and because of the need to train and support junior investigators proposing clinical investigations in frail, older adults. This initiative is closely aligned with the JHU Division of Geriatric Medicine and Gerontology's goals of integrating frailty-related research into clinical practice. The specific aims of RC3 are 1) to provide supported OAIC investigators with comprehensive training, mentorship and access to expertise in clinical research, 2) to provide the oversight necessary to ensure optimal and safe performance of clinical studies, 3) to provide clinical research space and assistance with all aspects of protocol development, data collection, and recruitment of human subjects as needed, and 4) to maintain and further develop an active registry of older adults characterized for frailty and consented to be contacted for additional aging and frailty related studies. A core leader with substantial clinical research expertise in aging and HIV-related metabolic studies, and who also leads a core and infrastructure in the JHU Institute of Clinical and Translational Research (ICTR), will facilitate the development, implementation, and conduct of both clinical physiological studies and clinical trials in this core. A highly skilled and experienced research program manager with expertise in recruitment of older adults and in the measurement of frailty and mobility, along with a team of experienced recruiters, will facilitate completion of Core aims. These aims will be carried out in close collaboration with the leaders of all other resource cores. Additional resources are provided by the ICTR, which will help ensure optimal study design, implementation, and interpretation of results, and Fast Forward, a translationally-focused unit at JHU will facilitate health technology development. This core will play a crucial role in the training of junior investigators engaged in Research Education Component (REC) activities and in pilot/exploratory studies, conduct developmental research as needed and will newly engage community advisory boards to strengthen stakeholder input and maximize research relevance. RC3 will continue to accelerate the pace of translation of the important biological findings being generated in this OAIC into frailty-related clinical studies that promote the maintenance of independence in older adults.